Peptide backbone modifications to enhance and study protein folding and binding

PROJECT SUMMARY/ABSTRACT
The objective in this application is to exploit stereochemically robust thioamides, at any point in the peptide se-
quence, as biophysical probes to address current barriers in peptide synthesis, folding, and drug discovery.
There is a perception that current methods to incorporate thioamides into peptides are sufficient. However, as
an example, the rapid racemization of the alpha-carbon stereochemistry of thioamide residues during synthesis
belies that perception. Indeed, a survey of reported peptides containing thioamides points to these limitations.
The majority of ‘successful’ sequences incorporate the thioamide close to the N-terminus, where exposure to
synthetic reagents is necessarily minimized during Fmoc solid-phase peptide synthesis (SPPS) procedures.
Thus, the instability of thioamides during Fmoc SPPS present a significant barrier to the synthesis and evalua-
tion of thioamide peptides, and restricts the sequence space in which thioamides can be employed. Anecdotal
reports indicate that many labs have wished to employ thioamides in a variety of peptide studies, but a lack of
documented pitfalls and synthetic options leads to intractable peptide products and, ultimately, abandonment
of such ventures. The approach in this proposal is to protect the thioamide, in analogy to the protection of the
functional groups of amino acid side chains, in order to preserve the thioamide moiety during peptide elonga-
tion. The rationale for this approach is that thioamide protection can be easily included within the standard
SPPS work-flow to enable novel applications in peptide synthesis, backbone modification, and protein-drug
interactions. The research plans of this project will exploit thioamides to probe protein folding and site-selective
insertion other chemistries. Thioamides will be employed in previously uncharted sequence space to address
fundamental questions in protein folding. We will also develop methods to transform thioamides into functional
groups that will unlock new constrained peptide scaffolds. Peptides with persistent structure hold tremendous
promise as therapeutics to bridge the performance gap between small molecules and biologics. Finally, this
work will identify strategies to interrogate and target therapeutically relevant protein-protein interfaces. Interac-
tions between hydrogen bond donors and acceptors of the main-chain of a peptide and a protein binding target
are underutilized in drug design. Based on structural bioinformatics, new strategies to identify underutilized in-
teractions at protein-protein interfaces (PPIs) will assist in the design of more potent inhibitors. Other work will
also develop new tools to interrogate PPIs for which very little structural information may be available to inform
future experimental design. The proposed research is innovative because it represents a substantive departure
from the status quo by developing and employing new methods to preserve thioamide stability, which promises
to unlock new research horizons. The contribution is significant because it is expected to have broad im-
portance in both the study of protein folding and the development of bioactive molecules.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because new methods to support basic research and fundamental studies in protein folding and function are expected to open new avenues for therapeutic intervention. The proposed program is relevant to the part of NIH’s mission that pertains to expanding the knowledge base to address the causes, diagnosis, prevention, and cure of human diseases.